Molecular Basis of mRNA Export

TITLE
Molecular basis of mRNA export
ABSTRACT
In eukaryotes, the genetic information encoded in the chromatin is stored within the nucleus. For genetic programs
to be executed, folded proteins, ribonucleic acids, and assembled macromolecular complexes must be transported
across the nuclear envelope. Nuclear pore complexes (NPCs) are exclusive gateways for the regulated
bidirectional exchange of macromolecules between the nucleus and cytoplasm. In humans, NPCs are assembled
from multiple copies of 35 different proteins known as nucleoporins (nups) that give rise to a ~1,000-protein
cylindrical structure spanning the nuclear envelope with a molecular mass of ~120 million Daltons. Due to its size
and flexibility, obtaining an atomic structure of the NPC has been a formidable task that we have overcome over
the last two decades with a divide-and-conquer approach. This approach relies on biochemical reconstitution and
nup-nup interaction mapping, along with high-resolution structure determination of nups and nup complexes,
combined with lower resolution cryo-electron tomography (cryoET) and in vivo validation. These efforts have
resulted in a near-atomic composite structure accounting for ~90% of the human NPC’s mass. However, critical
aspects of both its structure and function remain unexplored. The NPC’s cytoplasmic face harbors nups that
mediate interactions between mobile transport factors and their protein or ribonucleic acid cargoes, as well as the
machinery that dismantles messenger ribonucleoprotein particles (mRNPs) as they emerge from the NPC’s central
transport channel, irreversibly releasing mRNA into the cytoplasm. Notably, genetic variations in these nups are
prominently associated with various human diseases, including neurodegenerative and neoplastic disorders, and
heightened susceptibility to viral infections. We have previously reconstituted nup complexes of fungal NPCs’
cytoplasmic faces, enabling the systematic dissection of their nup-nup interactome. We now propose to perform
an equivalent reconstitution of the human NPC’s cytoplasmic face using recombinantly expressed and highly
purified proteins. Our second goal is to expand our high-resolution structural characterization to still unresolved
parts of the NPC. Third, we will functionally characterize previously identified RNA-binding events involving
cytoplasmic nups and the mobile RNA-transporting machinery by determining high-resolution structures and
assessing their functional relevance using in vitro activity assays and cell-based assays for nucleocytoplasmic
cargo transport. Finally, we will investigate the mechanism of action of the ORF6 virulence factor from SARS-CoV-2
and related sarbecoviruses. We will employ a multidisciplinary approach to gain atomic-level insights into ORF6's
interactions with the NPC and the nucleocytoplasmic transport machinery, as well as the effects these interactions
have on nuclear transport, mRNA export, and NPC integrity. Overall, our research will contribute to understanding
the NPC’s role in mRNA export and the viral interference mechanisms targeting this process, providing atomic-
level detail toward addressing this fundamental cell biological question and the molecular basis for the development
of antiviral treatments.

Public health relevance
PROJECT NARRATIVE The human genome is stored in the nucleus, a compartment segregated by a double membrane which is spanned by large proteinaceous assemblies acting as its exclusive and selective gateways, the so-called nuclear pore complexes (NPCs). As such, defects in the NPC are associated with a broad set of human diseases, including aggressive forms of cancer and neurodegenerative disorders, and its components are commonly targeted by many viruses to dampen the host’s antiviral response. Our research focuses on obtaining atomic-level snapshots of the NPC to understand how it mediates the relay of information encoded by the genome, and how its dysfunction relates to human health and disease.